Clinical Center for Cholestatic Liver Disease in Children

PROJECT SUMMARY/ABSTRACT
We propose to remain a Member of the Childhood Liver Disease Research Network (ChiLDReN). As a
Charter Member of the Network, our proposal represents a logical extension of the long-standing commitment
of our Center to improve the care of children with chronic liver disease through innovative patient-based
research. In the previous grant cycles, we worked collaboratively with investigators from other Centers and
with the Scientific Data Coordinating Center to build a strong infrastructure to conduct patient-based studies on
biliary atresia, cholestatic syndromes, mitochondrial hepatopathies, and primary sclerosing cholangitis (PSC).
Our key contributions in the previous cycle included: 1) leadership and/or partnership in the development of
network-wide clinical studies, with data analyses and publication of 34 original manuscripts of which 6 had lead
authors from Cincinnati; 2) completion of the PRIME and IMAGINE2 trials; 3) leadership in protocol
development and implementation of the PSC Observational Study; 4) leadership in whole exome sequencing
analysis of patients with mitochondrial hepatopathy; 5) high enrollment and retention of
subjects into prospective studies, including the PSC and FORCE studies; 6) timely processing of liver tissue by
the staff of RNA Purification Service and Bile Acid Analysis Service to support Network studies; and 7)
development of an MRI Core in collaboration with Perspectum Diagnostics to apply Al based analytics to
quantitatively predict biliary damage and liver fibrosis. We completed ancillary studies on the genetic basis of
intrahepatic cholestasis, the liver transcriptome in biliary atresia, and proteomic plasma biomarkers of portal
hypertension. We look forward to significantly contributing to the scientific goals and operational excellence of
ChiLDReN through four aims. In Aim 1, we will enroll subjects into prospective ChiLDReN protocols to enable
observational studies and translational science. This will be done by pursuing high enrollment rate of subjects
into approved protocols, with the timely collection and submission of data and tissue samples to meet the
enrollment goals established by the Network. In Aim 2, we will perform translational studies employing bulk
RNA and multiome sequencing of cryopreserved liver tissues, spatially resolved transcriptomics (SRT) on liver
sections, and Clink® based proteomics of plasma samples from patients with PSC to elucidate the role of the
TNF superfamily ligand TWEAK in the progression of biliary fibrosis in PSC. In Aim 3, we will assess the shortterm
efficacy and safety of systemic FXR agonist in the treatment of pediatric PSC. In Aim 4, we will establish a
Translational Science Coordination Center to support Network investigators with iPSC-derived model systems.
By pursuing the four aims, we will be well positioned to fully execute the new Network aims of pursuing
translational science projects and conducting trials to improve the outcome of children with cholestatic liver
diseases.

Public health relevance
PROJECT NARRATIVE We propose to remain a member of the Childhood Liver Disease Research Network (ChiLDReN) and to be a key contributor to the strong research infrastructure that enables translational science and clinical trials in children with biliary atresia, cholestatic syndromes, mitochondrial hepatopathies, and primary sclerosing cholangitis. We propose to investigate the role of the TNF superfamily member TWEAK in progression of biliary fibrosis and to determine the short-term efficacy and safety of treatment with systemic FXR agonist in pediatric PSC. We will establish a Translational Science Coordination Center to support ChiLDreN sites with induced pluripotent stem cell derived disease models.